REGULATION OF PHYSIOLOGICAL FUNCTIONS DURING AGING--NEUROTRANSMITTER RESPONSE

This project attempts to understand those mechanisms involved in age related changes in central nervous system responsiveness.